Optimizing an App-based Intervention for Sexual Minoritized Emerging Adults to Reduce Cannabis and Alcohol Co-use

PROJECT SUMMARY/ABSTRACT
This K23 award will support Dr. Florimbio, a clinician-scientist with experience researching and treating
substance use disorders, in becoming an independent researcher. Targeted research and training activities will
extend her knowledge and develop her expertise in delivering technology-driven adaptive interventions (e.g.,
smartphone app) to reduce cannabis/alcohol co-use (i.e., using both substances within a single time period
[e.g., past month], which could be during different occasions or simultaneously so drug effects overlap) among
sexual minoritized (SM) emerging adults (EAs; ages 18-25) in high-risk settings (i.e., college) where interven-
tions can be initiated. Training: Dr. Florimbio proposes a comprehensive training plan to (1) learn to identify key
components for co-use interventions for SM EA college students with involvement of the target population and
community partners, (2) acquire the essential skills and knowledge to use Sequential Multiple Assignment
Randomized Trials (SMART) to optimize adaptive interventions, and (3) learn best practices for collection and
analysis of intensive longitudinal data informing such interventions. Context: SM individuals often experience
additional stressors (e.g., minority stress, internalized sexual stigma) relative to non-minoritized individuals,
which may explain, in part, why SM EAs consume cannabis and alcohol at higher rates, have greater co-use,
and experience more consequences. Emerging adulthood is a period of increased substance use, instability,
and identity exploration, and, for about half of EAs, coincides with attending college, an environment that
connotes greater substance use risk. Efficacious interventions to reduce cannabis/alcohol co-use both for EA
college students (including those of SM identities) are lacking, with the college period being an ideal time to
address co-use in this population. Optimization of interventions to address variations in needs based on
individual factors and substance use severity is also a key next step for parsimonious delivery of interventions,
with some individuals needing a greater intervention dose or an extended dose over time. Responsive to NOT-
MD-22-012, the overall research objective is to develop and test an app-based adaptive intervention for SM EA
college students to reduce cannabis/alcohol co-use. Research Plan: The research aims include: Aim 1 which is
to develop theoretically-derived app-based intervention content via community-engaged methods with iterative
refinement of intervention components with end-user testing (4 rounds, n=5/round). Based on Aim 1 findings,
Aim 2 is to conduct a non-restricted pilot SMART with SM EA college students from multiple campuses to
assess feasibility and acceptability of the intervention components. Aim 2 will inform a full-scale SMART (R01
submission) to optimize technology-driven interventions to reduce co-use among SM EA college students. Key
innovations include state-of-the-art training, co-use intervention development with people with lived experience,
and the SMART design. Optimization of adaptive interventions for SM EAs to reduce cannabis/alcohol co-use
is a critical next step and will have high impact on substance use trajectories and health.

Public health relevance
PROJECT NARRATIVE Cannabis and alcohol are the two most widely used substances among emerging adults (~ ages 18-25), with elevated rates of use among sexual minoritized emerging adults in college settings. This K23 involves developing a technology-driven, app-based intervention with input from community partners (e.g., campus resource centers) and students with lived experience that will lead to the development of a novel adaptive intervention for sexual minoritized emerging adult college students who report cannabis and alcohol co-use (i.e., using both substances within the same period [e.g., past month], which could be different occasions or simultaneously so drug effects overlap). Given the high rates of smartphone use among this population, if the efficacy is established, this intervention will have great promise for increasing delivery of efficacious co-use interventions for sexual minoritized emerging adult college students, thereby benefiting public health.